PDGF-BB and the metastatic brain microenvironment

PROJECT SUMMARY
Recent studies by my group have highlighted the clinical relevance of platelet-derived growth factor-B
(PDGFB) secreted by malignant breast epithelial cells and its receptor, platelet-derived growth factor receptor
beta (PDGFRβ), expressed on cells of the mesenchymal lineage (e.g., fibroblasts, pericytes, astrocytes) in the
promotion of breast cancer metastasis to the brain (BCBM). Our studies revealed: (1) PDGFB ligand promotes
primary and intracranial breast tumor growth, (2) mesenchymal-specific PDGFRβ hyperactivity (Fsp1-
cre;PdgfrbD849V/+) promotes BCBM in mice, (3) PDGFB ligand expression in the primary breast tumor is
prognostic of brain metastases in human breast cancer patients, and (4) inhibition with a small molecule
selective PDGFR inhibitor (crenolanib) reduces intracranial tumor growth in mouse models of BCBM. This
published work discovered PDGFB-to-PDGFRβ signaling as a clinically relevant signaling node for predicting,
and potentially treating, BCBM. Our continued investigation into how breast cancer-derived PDGFB
mechanistically modulates the brain TME has further revealed previously unknown immuno-modulatory and
vascular effects. The current application will directly test the overarching hypothesis that breast cancer cells
expressing PDGFB completely transform the brain metastatic niche, both by creating a pro-tumorigenic
immune microenvironment and by invoking vascular changes. In Aim 1, the interaction between breast cancer
cells with/without PDGFB and the brain immune microenvironment will be evaluated in vitro (microglial co-
cultures and conditioned media experiments) and in vivo (intracardiac injections followed by brain
histopathological evaluation and high-plex spectral cytometry). This aim will also evaluate if PDGFB causes
changes in the microglial phagocytic response as well as shifts in anti-tumorigenic/pro-tumorigenic myeloid cell
phenotypes. These studies will be the first to directly test whether breast cancer-derived PDGFB drives
immune evasion in the brain metastatic microenvironment. In Aim 2, the interaction between breast cancer
cells with/without PDGFB and the brain microvasculature will be evaluated in vitro (BBB spheroids,
microfluidics) and in vivo (intracardiac injections followed by brain histopathological evaluation). This aim will
also evaluate a putative mechanism by which PDGFB functions in an autocrine manner to upregulate the pro-
angiogenic factor Angiopoietin-1, and whether these vascular changes can be ablated with small molecule
inhibitors of PDGFRβ and/or Tie2 (angiopoietin receptor). These studies will be the first to directly test the
hypothesis that breast cancer-derived PDGFB alters the brain microvasculature indirectly through an autocrine
PDGFB-PDGFRβ-Ang1 axis. Upon completion of the proposed study, we will have determined potentially
targetable mechanism(s) by which PDGFB pre-conditions the brain microenvironment allowing for metastasis
to this site.

Public health relevance
PROJECT NARRATIVE Women diagnosed with breast cancer-associated brain metastases (BCBM) have an unacceptable median overall survival rate of 10-11 months. A major knowledge gap in understanding brain metastasis biology is the functional interplay between tumor cells and the metastatic brain tumor microenvironment (TME). The current application will advance this field by directly examining novel mechanisms of how the PDGFB–to-PDGFRβ signaling node, which is potentially druggable, promotes BCBM by creating a pro-tumorigenic immune microenvironment and by invoking vascular changes in collaboration with Angiopoietin-1.